Metal-catalyzed transformations of unsaturated compounds

Project summary
Organic molecules play an important role in a number of research areas relevant to human health,
including biology, medicine, and drug development. One of the goals of synthetic organic
chemistry is to facilitate discovery in these fields by providing access to organic molecules of
increasing complexity and variety, and by expanding our ability to efficiently manipulate their
structure and their properties. A critical part of the efforts toward this goal is the development of
new organic transformations. The goal of the research described in this proposal is the
development of two new classes of reactions: 1) anti-selective hydroalkylation of terminal alkynes.
2) Differential dihydrofunctionalization of alkynes. Once successfully developed, these
transformations will greatly increase the complexity and versatility of products that can be
obtained directly from alkynes. Considering the importance of alkynes as reactive intermediate in
organic chemistry, this will have significant impact on the synthesis of biologically relevant
compounds.

Public health relevance
Project narrative: The progress of modern medicine has been directly related to the increased ability of scientists to prepare and manipulate complex organic molecules used as pharmaceuticals and research tools in biology and medicine. We are developing new tools for organic synthesis that will contribute to our ability to access organic molecules of increasing complexity and variety, and facilitate their use in areas of research directly related to human health.